5-HT7 receptor modulation of cocaine effects

Summary
There is still no widely accepted pharmacological therapy available for cocaine use disorders (CUDs) while
over the past decade there has been a rise in cocaine use and overdoses. The psychoactive effects of cocaine
are primarily due to enhanced and prolonged actions of monoamine neurotransmitters, including serotonin (5-
HT). Among the receptors activated by 5HT, the 5-HT7 receptor (5-HT7R) plays a role in several neural
processes involved in CUDs, including learning and memory, neural plasticity, sleep, impulsivity, and
sensation-seeking. These receptors also modulate alcohol intake in preclinical models and 5-HT7R
polymorphisms have been linked to alcohol use disorders. It is therefore surprising that the role of 5-HT7Rs in
CUDs-related behaviors has not yet been explored. Our preliminary data in male rats suggests that 5-HT7R
agonist and antagonist drugs modulate cocaine self-administration and that the antagonist decreases cocaine-
seeking behavior. We hypothesize that 5-HT7R antagonists inhibit, whereas 5-HT7R agonists enhance, cocaine
reinforcement and motivation for cocaine. We will test this hypothesis in male and female rats given extended
access to cocaine daily to establish an addiction phenotype. We will then test effects of a 5-HT7R antagonist,
MC-RG19, and an agonist, AS-19, on cocaine self-administration using a within-session, dose-reduction
procedure whereby rats have access to 9 different doses of cocaine for 10 min each in descending order of
concentration. A behavioral economics analysis of demand curves generated from the results will be used to
estimate demand intensity and demand elasticity, which are thought to reflect the reinforcing and motivational
properties of cocaine, respectively. We will also examine effects of the 5-HT7R drugs on cocaine-induced
changes in gene expression, using immunohistochemistry of Fos protein as a marker of these changes. We
expect that the antagonist will decrease demand intensity and increase demand elasticity, whereas the agonist
will produce the opposite pattern of effects. A similar pattern of changes in cocaine-induced Fos expression is
expected in mesocorticolimbic brain regions that are involved in CUDs. This project will be the first to
characterize the role of 5-HT7Rs in cocaine self-administration. If our predictions are upheld, the results will
suggest that 5-HT7R antagonists may be useful as novel medications for CUDs. Region-specific changes in
Fos expression will shed light on the neuroanatomical mechanisms involved in the 5-HT7R drug effects on
cocaine self-administration.

Public health relevance
Project narrative There is an urgent need for medications to treat cocaine use disorders (CUDs). This research aims to demonstrate for the first time that serotonin 7 receptors modulate cocaine reinforcement and motivation, and if confirmed, will identify these receptors as a novel target for CUDs medications development with high potential for translation.